Mechanisms of Anthrax Virulence Factor AtxA.

DESCRIPTION (provided by applicant): Bacillus anthracis plasmid-borne gene atxA encodes a major regulator of anthrax toxin expression. Although its role in virulence has been confirmed genetically, the mechanistic details of its action remain obscure. We have discovered that its product, AtxA, binds to anthrax RNA polymerase in vivo, and demonstrated its transcriptional activity in vitro. Using our extensive and in many ways unique experience in elucidating structural and biochemical mechanisms of various bacterial regulators of gene expression we propose a comprehensive plan of AtxA structural and functional research. As a result of the proposed research a detailed understanding of AtxA role in the expression of the anthrax toxin will emerge, complete with in-depth investigation of the molecular mechanism of its action, thorough analysis of the interplay between the differential phosphorylation of this factor and its transcriptional activity, and a high resolution structure of this factor in the ON and OFF states. Altogether these insights would allow for a better understanding of anthrax virulence and pathogenicity, while serving as a starting point of the structure-based design of AtxA-based inhibitors of anthrax toxin production by this important zoonotic pathogen and a Category A agent. PUBLIC HEALTH RELEVANCE: Bacillis anthracis is a routine cause of zoonotic anthrax infections and has been used as a bioterrorist weapon on the US soil. We propose a comprehensive plan of biochemical and structural research of the main regulator of anthrax virulence and toxin production, transcription factor AtxA. As the result of this research, a detailed understanding of AtxA mechanism of action will emerge while necessary structural and biochemical information will be gathered for its evaluation as a target for knowledge-based drug design.

Public health relevance
Bacillis antracis is a routine cause of zoonotic anthrax infections and has been used as a bioterrorist weapon on the US soil. We propose a comprehensive plan of biochemical and structural research of the main regulator of anthrax virulence and toxin production, transcription factor AtxA. As the result of this research, a detailed understanding of AtxA mechanism of action will emerge while necessary structural and biochemical information will be gathered for its evaluation as a target for knowledge-based drug design.